Acellular composite hydrogel scaffolds for volumetric muscle regeneration

Project Summary
There are almost 5 million reconstructive procedures performed annually as a result of traumatic injury, cancer
ablation, cosmetic procedures, or combat injuries. The destruction or removal of large amounts of skeletal
muscle, termed volumetric muscle loss (VML), resulting from traumatic events such as car crashes or combat
injuries, represents a significant health concern. Skeletal muscle is highly vascularized, and relies on adequate
infiltration of blood vessels to repair and regenerate. The gold standard for VML repair is autologous grafting,
and is limited by reduced functional outcomes and inadequate host-mediated graft revascularization. Current
biomaterial-based tissue engineered approaches towards the repair of skeletal muscle tissue after VML rely on
passive neovascularization from the host, as opposed to actively recruiting vascular networks to accompany
satellite cell infiltration during repair. As such, there remains a significant need to develop materials that will
actively stimulate the development of vasculature that will guide organized and aligned skeletal muscle tissue
regeneration. We hypothesize that scaffolds that stimulate the rapid creation of a new vasculature and aligned
muscle tissue will significantly enhance skeletal muscle repair in VML injuries. To test this hypothesis, we will
create a class of biodegradable composite scaffolds that will be implanted into VML injuries to enable the
recruitment of endothelial cells and satellite cells. As such, the objective is to create a composite material that
promotes in situ regeneration of mature functional muscle tissue. To fabricate these scaffolds, collagen sponges
with defined, anisotropic architectures will be fabricated and embedded with angiogenic self-assembling peptide
hydrogels, termed SLan (Aim 1). Assessment of the mechanics of scaffolds will complement in vitro analyses of
cellular infiltration and compatibility to define material parameters that will induce aligned vascularized skeletal
muscle tissue. Scaffolds comprised of collagen, SLan, or composites will then be implanted into a murine model
of VML to assess the contribution of each material to enhance VML repair (Aim 2). Particular emphasis will be
placed on the ability of these scaffolds to support functional recovery as measured by muscular contraction in
longitudinal studies. Histologic assessments will characterize i) the cellular infiltrate and the contribution of
aligned scaffolds to guide organized skeletal muscle tissue growth, ii) the modulation of in situ neovascularization
and supporting structures, and iii) changes in inflammation. Ultimately, we aim to address two major limitations
within skeletal muscle tissue regeneration: i) inadequate vascularization of constructs in situ, and ii) the lack of
organized alignment of nascent myofibers during repair of VML injuries; both factors known to inhibit functional
recovery. These outcomes will result in the creation of a new class of composite materials to functionally drive
cellular infiltration with hydrogels that are specifically designed to recruit specific supporting structures necessary
for tissue regeneration and repair.

Public health relevance
Project Narrative There is a large, unmet clinical need to develop tissue engineered strategies to treat volumetric muscle loss. We propose the development of off-the-shelf materials that will promote rapid endogenous vascularization and organized skeletal muscle regeneration. Using microfabrication techniques and designer peptide materials, we will evaluate biodegradable composite scaffolds that will ultimately yield functional, organized skeletal muscle tissue in situ.